A New Approach to Modulating CAR T Cell Activity

Abstract
Chimeric antigen receptor (CAR) T cells targeting CD19 are highly effective in children with
refractory/relapsed acute lymphoblastic leukemia (ALL), including those with primary
refractory or CNS disease. Current CAR T cell therapies infuse patients with T cells
constitutively expressing CARs, which are not susceptible to any controllable regulation.
Cytokine release syndrome (CRS) and CAR-associated neurotoxicity (CAN), both of which
can be fatal, arise from uncontrolled CAR T cell activation and expansion. While a few
pharmacological management approaches have been attempted to overcome this issue, they
are often suboptimal. In addition, chronic B-cell aplasia from persistent CD19 CAR T cells
requires monthly infusions of immunoglobulin, which is burdensome and expensive, especially
for pediatric patients facing potentially a lifetime need. Here, we propose to develop a system
for controllable CAR T cells that can be turned on and off as needed. We have previously
demonstrated that exogenous expression of the tyrosine phosphatase SHP-1 acts as a
negative regulator to dampen T cell activation. Recently, we have developed an inducible and
reversible protein degradation system for SHP-1 by adapting the plant Auxin-induced degron
(AID) system for T cells. Combining these two tools in Aim 1, we propose to develop CD19
CAR T cells that will be kept basally dormant through overexpression of SHP-1. However,
upon administration of Auxin, the CAR T cells can be temporarily and reversibly activated
through the degradation of SHP-1. As the doses of Auxin sufficient to activate the AID system
had no significant toxicities in humans, we do not foresee a problem translating this system
into the clinic. In Aim 2, we will examine the efficacy of this novel CAR T cell system in a murine
model of ALL. In Aim 3, we will expand the studies to test whether this regulatable CAR T cells
system can control and/or limit CAR T cell-associated toxicities using a muring model of ALL,
CRS and neurotoxicity. Such an exogenously regulatable CAR T cell system may provide
clinicians a tool to avoid/limit severe CRS and CAN, and allow repopulation of the B-cell
compartment after a sufficient treatment course. This approach will greatly enhance the safety
of CD19 CAR T cells and is likely applicable to CARs for other malignancies, including solid
tumors, where on-target, off-tissue cytotoxicity is more problematic.

Public health relevance
Public Health Relevance Statement A recent new anti-cancer immunotherapy, chimeric antigen receptor (CAR) T cell therapy that specifically targets and kills tumor cells, has been highly successful in treating children and adults with leukemia who do not respond to any other treatment, saving many lives. However, these patients experience significant and sometimes life-threatening systemic (very high fever, very fast heart rate, very low blood pressure, etc.) and neurologic side effects (confusion, difficulty speaking, seizures, brain swelling, etc.), which can be fatal even under optimal drug management of these toxicities. Here, we aim to develop a new safer CAR T cells that is only active when the patient takes a plant-based medicine called Auxin, which would create a controllable CAR T cell therapy that is significantly safer in both the short and long term, thereby potentially preventing many ICU admissions and long hospital stays that are currently associated with CAR T cell therapies for leukemia.